Environmental Assessment of Estraqua? (Estradiol Type A Medical Article) for American Eels in Recirculating Aquaculture Systems (RAS)

RESEARCH & RELATED Other Project Information:
Section 7 Project Summary/Abstract
This Environmental Assessment project is required by the FDA Center for Veterinary
Medicine to complete the Environmental Assessment technical section of the new
animal drug application. This project will evaluate environmental risk factors based on
the properties of and proposed use of INAD 012-884 (Type A Medicated Article, 0.1%
estradiol (Estraqua®)) administered in feed (at a dosing rate of 5 ppm) to American eels
(Anguilla rostrata) in a recirculating aquaculture system (RAS). The study will provide
the basis for FDA CVM to make a regulatory conclusion, either a finding of no significant
effects (FONSI) or an environmental impact statement (EIS).

Public health relevance
Other Project Section 8 Project Narrative Development of estradiol as a veterinary drug for increasing the rate of weight gain in farmed American eels (Anguilla rostrata) could lead to the release of estradiol to the environment. The Environmental Assessment will present and critically evaluate information from the literature that will allow the FDA CVM to make a final regulatory decision [e.g., finding of no significant impacts (FONSI) or environmental impact statement (EIS)].